Maternal Mental and Physical Health Outcomes after Stillbirth and Infant Death

DESCRIPTION (provided by applicant): The goal of this research is to improve mental health care and outcomes of bereaved mothers after stillbirth and infant death. For every 100 live births in the United States, 1-2 mothers have a pregnancy complicated by a stillbirth or infant death, and African-American mothers are at particularly high risk. These devastating events are typically traumatic and life-altering experiences which put surviving parents at high risk for prolonged grief and psychiatric complications in the subsequent years. Little is known about the long-term mental health impact of perinatal loss on surviving mothers. In addition, while more than 70% of bereaved mothers are pregnant again within a year after a stillbirth, it is not known how mental health changes due to bereavement affect subsequent prenatal health behaviors or pregnancy outcomes after the loss. The proposed research utilizes both a longitudinal data analysis and a multi-year mail survey of bereaved and non-bereaved mothers. Study A links maternal and fetal/infant health datasets over 10 years following fetal or infant death to examine mental and physical health disorders, health care costs and utilization in subsequent years, and risk of new onset maternal mental illness. Study B will survey bereaved mothers and non-bereaved controls longitudinally to gather information about mental health and treatment over time, physical health, grief and bereavement, hospital care at the time of loss, and reproductive health and health behaviors during subsequent pregnancies.

Public health relevance
RELEVANCE While fetal/infant death is uncommon, it still affects more than one mother out of 100 and can profoundly impact bereaved mothers and may impact the outcomes of their subsequent pregnancies as well. Findings from this research may potentially help to identify populations of women at highest risk for mental illness after a traumatic loss, measure the impact of hospital care on maternal psychiatric morbidity, quantify the economic costs of maternal health care in the years following a loss, and improve fetal outcomes in subsequent pregnancies.